Developmental Research Program

PROJECT SUMMARY
The objectives of the Developmental Research Projects Program are to provide a continuous flow of new ideas
and projects to stimulate myeloma research in the context of the Myeloma SPORE. It encourages new research
directions and methodologies and facilitates collaborations. By providing initial support to pilot projects, it will
foster the development of new translational projects. It also allows the Myeloma SPORE to have participation
and recruitment of new investigators not only from the DF/HCC but also from outside institutions. Our
Developmental Research Program during the previous funding period was extremely successful, with two
projects in this renewal SPORE application directly evolving from prior Developmental Projects. This Program
will continue to rely on scientific and programmatic review by the Governance Committee, which will assure
selection of the most promising, highest quality, projects with high likelihood of translational impact. To achieve
this goal, we will:
1) Solicit applications and/or identify novel myeloma research projects
2) Evaluate these projects for funding,
3) Fund the most innovative developmental projects,
4) Re-evaluate projects for possible transition into full project status, and
5) Evaluate success of the program

Public health relevance
PROJECT NARRATIVE The Development Research Program is intended to attract Investigators to focus on Myeloma research in order to develop innovative and translational projects.